Prevention of behavior problems among preschool children in foster care through group-based foster caregiver training at the time of placement

Project Summary
Most children in foster care experience multiple forms of maltreatment, increasing risk for behavior problems
(e.g., aggression, noncompliance, suspensions/expulsions from preschool or daycare). The foster care system
is over-burdened and crisis-response oriented, limiting capacity to focus on prevention of behavior problems
with foster caregivers and children. The Chicago Parent Program (CPP) is an evidence-based 12-session
program (11 concurrent weeks, 1 one-month booster) with demonstrated significant and sustained
improvements in consistent discipline, parenting self-efficacy, and child behavior problems 1 year following
training. If available to foster caregivers, CPP could prevent or reduce behavior problems in foster youth,
decrease caregiver stress, increase self-efficacy and consistent discipline with caregivers, and prevent
unnecessary placement changes. However, adaptations to the existing program are necessary. The goal of
this study is to conduct a clinical trial of CPP adapted for foster caregivers of young children. This will be
accomplished through three aims: Aim 1: Adapt CPP to meet the unique needs of children ages 2-5 years
who are placed with foster caregivers (CPP-FC) and pilot delivery coordinated with mandated
healthcare visits (2 groups, 6-8 families). CPP content will be adapted (e.g., additional content targeting
trauma and child maltreatment, modified discussion of vignettes, additional role-play targeting specific foster
care scenarios). A stakeholder adaptation team, including 6 caregivers, has been established to guide
development of enhanced content. Aim 2: Assess the impact of CPP-FC on caregiver stress & confidence
in managing child behavior. Families (N = 300) will be randomized to CPP-FC or usual care, with
assessments at baseline, 3 months (end of training) and 6 months. CPP-FC is expected to reduce caregiver
stress and increase confidence. Aim 3: Assess the impact of CPP-FC on child behavior. Observations of
structured interactions between caregivers and children at baseline and 3-months will be collected along with
caregiver reports of child behaviors at baseline, 3 months, and 6 months. CPP-FC is expected to decrease
child behavior problems and result in fewer placement changes. If hypotheses are confirmed, this study will
provide an evidence-based model to prevent behavior problems in young foster children that could be spread
to other institutions.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) Young children in foster care are at high risk for behavior problems that contribute to social challenges with their caregivers and in other settings (e.g., school, daycare). The goal of this application is to evaluate the impact of the Chicago Parent Program adapted for Foster Care (CPP-FC), using a longitudinal randomized controlled trial of 300 caregivers. The findings from this study will demonstrate whether CPP-FC is effective in reducing behavior problems in young foster children and whether that contributes to reduced caregiver stress, increased caregiver confidence, and longer lengths of time that children remain with foster caregivers, avoiding unnecessary moves from one caregiver to another and improving child wellbeing.